Mechanisms of Pseudomonas aeruginosa adaptation, colonization, and host responses in children with artificial airways

This proposal presents a five-year research career development program studying Pseudomonas
aeruginosa evolution and phenotypic adaptations in patients with tracheostomy tubes (TT) and host responses
that promote airway colonization leading to ventilator-associated infections (VAI). The candidate, Glenn J.
Rapsinski, MD, PhD, is an Instructor of Pediatric Infectious Diseases at UPMC Children’s Hospital of
Pittsburgh and the University of Pittsburgh School of Medicine. The proposal augments the candidate’s
research skills and clinical experience in host-pathogen interactions by incorporating two new disciplines:
bacterial evolution and epithelial cell biology. The proposed studies and multifaceted training plan incorporate
course work, immersive training, and one-on-one mentorship to provide a skillset and interdisciplinary
perspective empowering his transition to an independent physician scientist studying bacterial adaptations and
host-pathogen interactions during device infections.
VAI, such as pneumonia and tracheitis, are a common complication of mechanical ventilation.
Ventilator-associated pneumonia alone costs ~$2.5 billion per year in the US. Children with TT comprise most
incidents of pediatric VAI. In most cases, previously colonizing organisms invade to cause acute infection of
the trachea or lungs. P. aeruginosa is the most common cause of VAI and adapts during other chronic airway
colonization. However, adaptations of TT colonizers and how these genetic or metabolic changes alter
pathogenic potential and host responses are unknown. My preliminary data suggest that P. aeruginosa
reduces acute virulence during TT airway colonization, airway epithelial function is altered by having a TT, and
that the host responds differently to adapted P. aeruginosa. The proposed Specific Aims are: (1) to define P.
aeruginosa diversity, persistence, and evolution in patients during TT colonization; (2) to determine TT-airway
environmental factors driving early P. aeruginosa airway adaption; and (3) to delineate host responses to TT-
adapted P. aeruginosa strains. I will define P. aeruginosa diversity and persistence using whole genome
sequencing of P. aeruginosa isolates obtained from patients with TT and adaptations will be identified among
variants within longitudinal isolates. I will also use an in vitro bacterial evolution model with media chemically
similar the human lung to determine the selective pressures in the host nutritional environment with and
without the TT surface. The effects of putative adaptations on host responses will be quantified using a
specialized in vitro primary lung epithelial cell and animal infection models. The proposal pioneers research
into P. aeruginosa evolution during TT colonization and host responses to adapted strains. The long-term goal
is to discover specific bacterial mutations and mutated pathways, and mechanisms of host colonization for
novel therapeutics that will be applicable to other medical device-associated infections.

Public health relevance
PROJECT NARRATIVE People requiring mechanical breathing support are at risk of infections that result in significant additional healthcare costs, disability, and death. Understanding how the bacteria in the airway evolve and how the airway cells respond to the bacteria are critical for reducing these infections. The goal of this proposal is to determine the ways that bacteria causing ventilator-associated infections adapt to the airway and influence airway cell function to maintain colonization.